Task A16 Neisseria gonorrhoeae mouse infection model

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.